The role of context in sleep-related memory reactivation in humans

PROJECT SUMMARY/ABSTRACT
Sleep is crucial for memory consolidation and its benefit is most commonly thought to occur via the reactivation
of memories, thereby strengthening the neural infrastructure supporting them. Theoretical accounts of sleep-
related consolidation focus on the process by which memories are independently strengthened, but in natural
settings individual memories never exist in a vacuum. Importantly, the context in which memories are embedded
during encoding governs retrieval and decision making behavior. However, context’s role in consolidation has
not been directly explored. The goal of the proposed project is to improve our fundamental understanding of
memory processes by developing an empirically-based framework unifying models of context’s effect on memory
and models of sleep-related consolidation (Aim 1; Experiments 1–3). Additionally, the framework may support
translational interventions to alter memories during sleep. Aim 2 (Experiments 4–5) will attempt to reinstate a
suppression context during sleep to effectively weaken memories. This effort will inform future work on alleviating
memory-related symptoms in clinical populations suffering from post-traumatic stress disorder. Whereas the
proof-of-concept for both aims will be demonstrated in the K99 phase of this award, the R00 phase will serve to
enhance the theoretical framework and establish external validity. Both the translational and basic-science arms
of this work will continue in parallel throughout my independent career, in which I will use my fully assembled
neurocognitive toolkit to explore sleep’s contribution to memory and the neural infrastructure supporting it.
The main behavioral manipulation used in this proposal is targeted memory reactivation, the unobtrusive
presentation of learning-related stimuli during sleep, thereby enhancing memory. Experiment 1 (K99 phase) tests
whether contexts may be reactivated directly and considers the interactions between reactivation-related benefits
of individual memories and contexts. Experiment 2 (K99 phase) investigates whether cues for individual
memories presented during sleep reactivate the learning context in a manner that propagates to other memories
contextually linked together. Experiment 3 (R00 phase) uses functional MRI pattern analysis techniques to reveal
whether contexts, individual memories or both are reactivated during natural, undisturbed sleep. Experiment 4
(K99 phase) attempts to embed individual memories in a previously unrelated context during sleep: a reactivated
“suppression” context (cued by an odor) will be presented with auditory cues linked to individual memories,
hypothetically weakening them during sleep. Experiment 5 (R00 phase) will use a similar technique to try and
alleviate distressful intrusive memories following a trauma manipulation in healthy participants.
For this project, I have assembled an expert mentorship team for the K99 phase, including leaders in functional
MRI pattern analysis, computational models of context and memory, and olfactory stimulation, covering the entire
scope of required expertise. Northwestern University has a vibrant cognitive neuroscience community, with the
required methodologies strongly represented, as well as all the needed equipment and facilities.

Public health relevance
PROJECT NARRATIVE Memories are highly dependent upon the context in which they are embedded, yet neurocognitive models of human sleep consolidation downplay the role of context and focus instead on the reactivation (or “replay”) of individual, isolated memory traces. This proposal will disentangle the roles of individual memories and generalized contexts in sleep-related reactivation using functional MRI, EEG and behavioral methods for sleep manipulation, thereby creating a unified framework linking the context-memory literature, the nonhuman replay literature, and the human reactivation literature. The possibility of reinstating context during sleep will be exploited to weaken memories reactivated in a suppression context, providing evidence for the translational nature of the developed framework and possibly paving the way toward non-invasive memory-altering interventions for healthy and clinical populations.